Computational Genomics of Signal Transduction

PROJECT SUMMARY
Signal transduction is a universal biological process vital to all organisms. Due to their central role in disease,
signal transduction systems in humans and in bacterial pathogens are the primary targets for drug design. Our
long-term goal is to understand how cells detect, transmit, and adapt to signals. The main focus of our research
is on bacterial signal transduction systems, with the goal of revealing their fundamental properties and
mechanisms at the molecular level. The main unanswered questions that we propose to address are: (1) Which
small molecule ligands are recognized by bacteria; (2) How did signaling networks evolve; and 3) Can we use
the knowledge obtained with bacterial systems to advance our understanding of their counterparts in humans,
especially with respect to disease. We propose to build on our previous findings and capitalize on our tools and
innovative approaches to obtain and capture this knowledge as predictive models. These models will be stored
in public databases, such as InterPro, NCBI Conserved Domain database, and our own Microbial Signal
Transduction (MiST) database. Current MiST capabilities will be further enhanced to better serve the scientific
community.

Public health relevance
NARRATIVE Signal transduction, a process by which chemical and physical signals are transmitted through a cell, has a profound impact on human health and signal transduction pathways in bacteria and in humans are attractive targets for drug design. Understanding how signal transduction pathways function in bacterial and human cells is thus vital for our progress towards understanding and treating various diseases ranging from bacterial infections to cancer. We will use comparative genomics to better understand fundamental principles and molecular mechanisms of signal transduction in bacteria and elements of signal transduction in humans that are conserved throughout the Tree of Life.